Molecular mechanisms of physical interactions between bacteria and their surroundings

Project Summary
To survive in diverse environments, bacteria must dynamically interact with their physical surroundings to sense
and incorporate stimuli into physiological responses. Bacteria often achieve this interplay between extracellular
cues and intracellular signaling by using surface-exposed nanomachines that connect the intracellular space to
the cell surface. The most broadly distributed surface-exposed nanomachines are appendages called type IV
pili (T4P) and evolutionarily related structures that are believed to have diverged from an ancient nanomachine
found in the last universal common ancestor. T4P are highly dynamic, employing multiple molecular motors to
power cycles of extension and retraction that are essential for many behaviors, making them an ideal system for
understanding the dynamic exchange between cells and their physical environments. Despite their broad
distribution and importance in many biological processes, little is known about the fundamental biology behind
T4P dynamics, regulation, and structure. We will use a combination of genetics, cell biology, biophysics, and
biochemical techniques to dissect the fundamental biology of T4P. We will employ multiple model organisms
including Caulobacter crescentus, Vibrio cholerae, and Acinetobacter species that all produce T4P for a
comparative biology approach across different T4P. Our prior experience and expertise working in these systems
will enable us to interrogate how T4P regulatory mechanisms evolve to respond to environmental stimuli and
how these regulatory differences influence behavioral outputs. Our five-year goals include understanding the
basic mechanisms driving T4P dynamics, how dynamics are regulated, and the consequences of different
regulatory mechanisms on bacterial behavior and physiology. This work will address several key questions,
including: 1) what are the main factors influencing dynamics? 2) what mechanisms control subcellular localization
and patterning? And 3) how do structural subunits of T4P determine their functional and mechanical properties
to influence diverse behavioral outputs? This work will provide critical insight into T4P regulation and dynamics
that will result in better understanding of the physical interactions between cells and their environments and
enable the development of tools to hinder or control T4P function in the broad bacterial behaviors they elicit. The
fundamental discoveries made through our study of T4P will also reveal general aspects of biology including
insight into the underlying mechanics of molecular motors, the mechanisms controlling intracellular spatial
organization, and the relationship between protein structure and function.

Public health relevance
Project Narrative Type IV pili (T4P) are bacterial appendages that are critical for behaviors including DNA uptake during natural transformation, biofilm formation, twitching motility, protein secretion, and virulence. Using several model organisms with emphasis on Acinetobacter species, we will characterize the fundamental mechanisms driving T4P dynamics, regulation, and function. This work will lay the groundwork for developing new methods to control or hinder T4P and the broad behaviors they elicit in diverse bacterial pathogens.